Administrative Core

PROJECT SUMMARY
The Administrative Core provides strong, centralized scientific and administrative leadership to the PPG, which
facilitates synergistic interactions between the four projects and two scientific cores and maintains the overall
focus of the program project. The Core will coordinate the research mission, monitor timelines for achieving
research milestones, coordinate and integrate PPG activities, and implement a plan for regular evaluation of
scientific progress. Drs. Chak, Guda, and Garman will be assisted by the Executive Steering Committee (project
and core leaders), as well as the Advisory Board, which includes internal and external members. The
Administrative Core will oversee annual budgets, monitor expenses and provide monthly statements of financial
activities to the projects and scientific cores. In addition, all program-related meetings will be scheduled through
the core. These include the weekly meeting of the Executive Steering Committee, monthly Cross-Program
Progress Seminars, and the Annual Program Retreat. In addition, generation of materials to be reviewed by
the Advisory Board will be handled through the Administrative Core. Finally, the Administrative Core will prepare,
generate and assemble materials required for the annual progress reports and will ensure that all additional NIH
and institutional reporting requirements concerning PPG activities are fulfilled in a timely manner.

Public health relevance
PROJECT NARRATIVE Barrett's esophagus is a complex disorder and patients with Barrett's esophagus are at an increased risk of developing esophageal adenocarcinoma, a lethal and most common esophageal malignancy in the United States. To date, the mechanisms contributing to the onset and malignant progression of Barrett's esophagus remain poorly understood. Our proposed studies are accordingly designed to unravel the molecular underpinnings of Barrett's esophagus and associated esophageal malignancy, with an overarching goal of developing evidence-based biomarkers and rational chemopreventive/therapeutic strategies for this increasingly prevalent and complex disease.